A Thermoreversible 3D Manufacturing Platform for Scalable Production of Dopaminergic Neurons for Parkinson's Disease Therapy

PROJECT SUMMARY
Parkinson's Disease (PD) affects more than 1 million adults in the U.S, and cell replacement therapy
(CRT) using human embryonic stem cell (hESC) derived midbrain dopaminergic (DA) neurons has shown
great promise in animal studies in alleviating symptoms of PD. However, current manufacturing strategies for
cell therapies are constrained by the industry standard format – monolayer, 2-dimensional (2D), cell culture –
that additionally suffer from the lot-to-lot variability of animal-derived materials such as Matrigel as well as
harsh enzymatic cell retrieval methods. Axent Biosciences Inc. is developing a proprietary 3-dimensional (3D)
hydrogel based culture method to offer a critical extra dimension for cells to expand during production and
thereby significantly increase the cell quantity produced per culture volume. Furthermore, our proprietary
hydrogel technology is fully synthetic and avoids animal derived products, and its temperature responsive
phase change enables gentle, high viability cell harvesting by cooling. We have shown that our 3D culture
approach enables highly scalable expansion of hESCs, followed by 3D differentiation to DA neurons. Notably,
we have achieved up to 25 times the quantity of potent DA neurons produced per culture volume with our 3D
culture format compared to standard 2D formats. Moving forward, our overall objective is to scale up our 3D
cell manufacturing process to produce high-purity, functional hESC-derived DA neurons and validate their in
vitro and in vivo functionality to develop our Chemistry, Manufacturing, and Controls (CMC) towards filing an
Investigational New Drug (IND) application. In Aim 1, we will scale up production of hESC-derived DA neurons
to a pilot bioreactor capable of suppling sufficient numbers of cells for a Phase I clinical trial. In Aim 2, we will
develop a purification strategy to remove residual contaminating cell types. In Aim 3, we will validate in vivo
functionality of DA neurons produced in 3D bioreactor process and will benchmark against DA neurons
generated in a conventional 2D production format. Successful completion of these aims will yield the basis for
a cGMP-compliant manufacturing platform capable of producing higher quantities of functional DA neurons per
culture volume compared to current 2D culture formats and thereby overcome a significant bottleneck for the
development of PD cell therapies. Furthermore, our manufacturing process is generalizable and can be tuned
to manufacture numerous cell types from hESCs. Finally, the purification process will minimize the risk of
contaminating cell types in the final formulation, thereby increasing the safety profile of our candidate therapy
in preparation for an FDA INTERACT meeting and subsequent filing of an IND application. To build toward this
goal further in a Phase II SBIR proposal, we will include IND-enabling preclinical studies – particularly a 9-
month animal study to validate safety – to progress translation of our DA neuron therapy for PD to the clinic.

Public health relevance
PROJECT NARRATIVE Parkinson's disease (PD) affects more than 1 million adults in the U.S, and cell replacement therapy (CRT) using human dopaminergic (DA) neurons has fortunately shown great promise in alleviating symptoms of PD in animal studies and human trials. However, manufacturing sufficient numbers of cells for clinical development and commercialization is a major challenge. To overcome this severe bottleneck, Axent Biosciences is developing an innovative 3D manufacturing strategy for producing consistent and high-quality hESC-derived DA neurons that will make cell therapies accessible to the large patient population in need.